New approach methodologies to assess reproductive risks of memory-enhancing dietary supplements

Proposal Abstract
Dietary supplements, including memory-enhancing compounds such as vinpocetine, are widely
available to consumers despite limited regulatory oversight on their reproductive safety. The U.S. Food and
Drug Administration (FDA) has issued warnings regarding the potential teratogenicity of vinpocetine based on
animal studies, yet human-relevant data remain scarce. This project aims to develop and apply pluripotent
stem cell-based models as new approach methodologies (NAMs) to evaluate the teratogenicity of vinpocetine
and related memory-enhancing supplements. These models, derived from both mouse and human stem cells,
recapitulate key embryonic morphogenesis processes, enabling mechanistic investigations into teratogenic
effects, as reported in our published studies. In Aim 1, we will characterize the molecular impact of vinpocetine
on these morphogenesis models by performing whole-genome transcriptomic analyses. Bioinformatic analysis
of differentially expressed genes will reveal molecular pathways that are disrupted by vinpocetine. In Aim 2,
we will identify molecular targets of vinpocetine responsible for its teratogenicity. While the purported cognitive
benefits of vinpocetine are linked to its inhibition of phosphodiesterase 1 and IκB kinase β, whether these
targets mediate its teratogenicity remains unknown. To address this, we will perform loss-of-function studies
for these two genes in our morphogenesis models and compare the resulting phenotypes to those treated with
vinpocetine. In Aim 3, we will use our morphogenesis models to assess the potential teratogenicity of
alternative memory-enhancing supplements. With vinpocetine identified by the FDA as a potential teratogen,
consumers may turn to alternative supplements, many of which lack developmental and reproductive toxicity
data. Using our morphogenesis models, we will evaluate the adverse effects of commonly marketed memory-
enhancing supplements by analyzing concentration-effects relationships, which can be used to guide future
safety assessment and regulatory actions for these supplements. This proposal combines innovative stem cell
technology, transcriptomic analyses, and human-relevant endpoints to advance teratogenicity testing beyond
traditional animal-based studies. Findings from this project will contribute to public health by informing
regulatory considerations for dietary supplement safety. Additionally, this work will establish a versatile NAM
platform to improve and accelerate the reproductive risk assessment of chemicals, offering cost-effective, time-
efficient, and ethical alternative to conventional animal-based approaches.

Public health relevance
Proposal Narrative This project aims to apply pluripotent stem cell-based assays as new approach methodologies (NAMs) to assess the reproductive risks of vinpocetine and related memory-enhancing dietary supplements. By leveraging human-relevant, non-animal models, this study will generate mechanistic insights into potential teratogenic effects while addressing regulatory gaps in dietary supplement safety testing. The findings will help advance non-animal alternatives for reproductive risk assessment of dietary supplements.